SUNY Upstate Bridges to the Baccalaureate Program

Program Director/Principal Investigator: Savage, Lisa
Project Summary:
Binghamton University (BU) will continue our successful 20-yr affiliation with Monroe
Community College (MCC), Onondaga Community College (OCC) and Westchester Community
College (WCC) in the Upstate Bridges to the Baccalaureate Program. Our Bridges Program has
under-represented (UR) student transfer (91%) and baccalaureate degree completion rates
(84%) much greater the national (31.5% transfer rate; 46% degree completion) and New York
State degree completion rates (60.2% overall and 38% for UR). Our long-term success is based
on a partnership that successfully prepares UR students to take part in the biomedical
educational and research enterprise (72% from 2007-2018; and the recent cycle from 2014 over
90%, of students earned baccalaureate STEM degrees). However, we believe that we can
improve on our success with activities outlined in the following Aims: (1) To strengthen scientific
literacy and promote confidence in scientific ability in early stage UR students. This is aimed at
fostering persistence in biomedical science education and career choice. To enhance interest in
careers in science, we will provide seminars at the CCs with a focus on science education and
career awareness. We will also offer a Scientific Bootcamp at the beginning of our 8-wk
Summer Research Experience to provide instruction on basic scientific skills and scientific rigor.
In addition, the grant will fund supplementary math and science skills development at the CCs to
improve UR students’ science preparedness; (2) Provide an authentic, immersive, and rigorous
research experience at BU to fortify commitment and enthusiasm for biomedical sciences. This
will be accomplished by an 8-wk rigorous program of faculty-mentored summer research
experience at BU; (3) We will promote advanced scientific education and professionalism as a
way of reinforcing the proportion (currently 82%) of Bridges Scholars that obtain baccalaureate
degrees in the biomedical and behavioral sciences. Bridges Scholars that transfer to BU will
enroll in a Culture of Science course that includes instruction in Individual Development Plans,
research ethics and communication of research. In addition, we fund research internships for a
subset of Bridges Scholars during the academic year. The proposed program will promote the
development of independent or honors research projects with research-active faculty mentors.
We will also support travel to present independent research at discipline-specific international
scientific conferences. The development of a strong science skill set and science career identity
among UR students is critical for their continuation on the science career pathway.

Public health relevance
PUBLIC HEALTH RELEVANCE: The long-term goal of the SUNY Upstate Bridges to the Baccalaureate Program is to increase the number of under-represented students who transfer from community college and complete the baccalaureate degrees in disciplines relevant to biomedical and behavioral sciences. The inclusion of underrepresented groups in the biomedical and behavior science workforce is critical to reducing health disparities and improving the health of all people in the United States.